Impact of cocaine-associated cues and contexts on adolescent relapse

PROJECT SUMMARY
Adolescence is a critical juncture when initiation of drug use intersects with profound developmental and
structural changes in the brain. It is well known that adolescent drug use increases the risk to develop
substance use disorders (SUDs) later in life, but the mechanisms that confer this vulnerability are not
understood. SUDs are defined by cycles of use, abstinence, and relapse. Intense craving during drug-free
periods is often triggered by cues and environmental contexts associated with previous use. In adolescents,
there is a gap in knowledge on the fundamental brain and behavioral changes occurring during abstinence.
We established an abbreviated model of Coc-SA (ABRV Coc-SA) that permits us to examine relapse during
adolescence. We find that adolescent rats show incubation of craving in a previous cocaine-paired context,
whereas adults do not. Our data suggest that adolescent rats are more sensitive to cocaine-related
contextual stimuli compared to adults, which contrasts with their reduced reactivity to cocaine-paired cues
(i.e. conditioned stimuli- CS). Our overall goal is to provide a comprehensive understanding of the distinct
cocaine-associated stimuli that trigger craving and relapse in adolescent rats. Aim 1 will test the working
hypothesis that context-induced incubation of cocaine seeking in adolescent rats results from earlier onset
of incubation compared to adults. Adolescent and adult male and female rats will receive ABRV Coc-SA in
an context with diffuse background stimuli, lever extinction in a second context (no reward). After 1, 15 or 30
days of abstinence, Relapse tests will occur in the previous cocaine context. Aim 2 will test the working
hypothesis that incubation of cocaine seeking in adolescent rats is specific to contextual stimuli rather than
cocaine-paired CSs. Adolescent and adult male and female rats will receive ABRV Coc-SA, with cocaine
infusion paired with CS, lever extinction will occur in the same context (no reward, no CS). After 1, 15 or 30
days of abstinence, Relapse Tests will occur with response-contingent presentation of cocaine-paired CS.
Our proposal will establish foundational knowledge about the unique triggers of craving in an adolescent rat
model. This knowledge is critical to inform improved behavioral interventions targeted to reduce relapse in
human adolescents.

Public health relevance
PROJECT NARRATIVE Drug use during adolescence increases the risk to develop substance use disorders. Up to 86% of adolescents relapse after leaving treatment centers, which suggests that adult relapse prevention strategies that aim to diminish the reactivity to drug-associated cues are insufficient treatments for adolescents. The current proposal will establish foundational knowledge about the unique triggers of craving in an adolescent rat model, which is critical to inform improved behavioral interventions targeted to reduce relapse in human adolescents.